Cell-free DNA as a marker of progression in Alzheimer's dementia and its role in chronic inflammation

PROJECT ABSTRACT/SUMMARY:
Mild cognitive impairment (MCI) is defined as having impaired cognition in one or more domains with minimal
limitations to daily life activities and may represent a timepoint at which interventions for Alzheimer’s disease
(AD) can be implemented. However, there is significant variability in rates of progression from MCI to AD;
therefore, it is critical to non-invasively identify individuals at highest risk of disease progression. One proposed
marker of disease progression is cell-free DNA (cf-DNA), which is released from cell death processes. Measuring
serum cf-DNA conveys information about cell death mechanisms that can help us better understand energy
changes in the dying cells. Determining the connections between cf-DNA and immune system activation allows
us to better recognize factors that contribute to chronic inflammation in MCI and AD. This study hypothesizes
that increased cf-DNA levels in individuals with MCI are associated with faster rates of progression to AD, and
that cf-DNA contributes to AD-associated chronic inflammation via activation of the nuclear factor kappa-B (NF-
kB) pathway. Digital PCR will be used to measure cf-DNA levels in serum of individuals with MCI and normal
cognition and associations with rates of cognitive decline will be studied (Aim 1). Differentiated human neuronal
cell lines treated with purified cf-DNA from individuals with MCI and normal cognition will be evaluated for
changes in inflammatory cytokine production, activation of NF-kB signaling, and cell death (Aim 2). This
innovative study has the potential to identify important immune signaling pathways to examine further in the
context of AD and can directly impact patient care by utilizing cf-DNA as a marker associated with rates of
disease progression in individuals with MCI.

Public health relevance
PROJECT NARRATIVE: Circulating cell-free DNA (cf-DNA) fragments are detectable in the blood stream following cell death processes and can activate the innate immune system. This study will evaluate relationships between cf-DNA and rates of progression to Alzheimer’s disease (AD) among individuals with mild cognitive impairment (MCI). Additionally, this work will help us understand how cf-DNA may contribute to AD-associated chronic inflammation in neurons.